Exploration and benchmarking of duplex sequencing

ABSTRACT
Duplex sequencing offers a much-reduced error rate of sequencing and allows for the detection
of somatic variation at the single molecule level. Duplex sequencing is part of the proposed
experimental design of three GCCs (BCM, Broad and NYGC), although each center plans to use
a different technology: NanoSeq/CompDuplex (BCM), CODEC (Broad) or Ultima duplex (NYGC).
In addition, TTDs are further developing a tagmentation-based duplex sequencing assay (VISTA-
seq, BCH - Choudhury), long-read sequencing with ultralow error rates (HiDEF-seq, NYU) and a
single-cell version of the CompDuplex method (BCM).
Throughout our existing collaborative project, we have applied each of these technologies to the
COLO829 cell line mixture and benchmarking tissues from the SMaHT Network. Following full
analysis and dissemination of the benchmarking results, there is a need within the SMaHT
Network to i) scale up existing duplex technologies at the GCC, ii) implement duplex technologies
developed at TTDs at the GCC, and iii) explore the application of ultradeep, targeted duplex
sequencing for variant validation and driver discovery.
Here, we seek to address those needs by scaling up production of CODEC at the Broad and by
testing, implementing and applying the newly developed HiDEF-seq method. We will apply these
methods to all samples from two Tier 1 SMAHT donors. In addition, we will explore using targeted
duplex sequencing approaches, based on CODEC, HiDEF-seq or NanoSeq, for variant validation
and detection of positive selection through discovery of somatic mutations in key genes or
regions.

Public health relevance
NARRATIVE Duplex sequencing offers a way to robustly interrogate the landscape of somatic mutations at single molecule resolution through reducing the error rate of sequencing. A variety of such duplex sequencing approaches are being implemented across the SMaHT Network. We propose to scale up the efforts around duplex sequencing by 1) productionizing CODEC, 2) testing, and implementing HiDEF-seq at the Broad Institute, and 3) exploring the use of targeted duplex sequencing (CODEC, HiDEF-seq, NanoSeq or other) for mutation validation and driver discovery.